Effects of Altering Social Connectedness on Health

Project Summary
Social life profoundly influences health. The ability to treat and prevent illness and improve human health
therefore requires a detailed understanding of the complex mechanisms underlying the influence of social
complexity on biological systems. Such understanding is key to the development of new interventions to
improve public health. Past studies have demonstrated the critical contribution of social relationships in
shaping health outcomes but are limited in application because such studies rarely consider social support or
health as “complex systems”. As a result, we lack a deep understanding of how and why individuals within
families, and families within communities, remain healthy or become unhealthy in the context of their social
environments. In this application, our proposed research overcomes this limitation by adopting an intervention-
based experimental and computational systems science approach that provides methods uniquely suited to
elucidate the complex mechanisms by which social systems influence health by modeling short- and longer
term integrative effects of social life on health in a proven nonhuman primate model.

Public health relevance
Project Narrative The ability to treat and prevent illness and improve human health requires not only a detailed understanding of the complex interplay of biological systems contributing to disease processes but also the mechanisms underlying the influence of social complexity on biological systems. The systems science approach provides methods uniquely suited to elucidate the mechanisms by which social systems influence health. The proposed research adopts this approach by modeling the short- and long-term effects of social interventions on the multiscale and multilayer networks and their effects on biomarkers of individual health in a well- established nonhuman primate model.